SUPPORT FOR THE RCADS DATA COLLECTION MEASURE

The purpose is to provide support to users of the copyrighted Revised Children’s Anxiety and Depression Scale (RCADS) family of data collection instruments. The
objectives is to 1) design a website for RCADS users; 2) create and maintain a help desk to assist RCADS users; and 3) create and maintain a system to allow RCADS users to request modifications to the copyrighted RCADS instruments.